A Geometric and Morphoelastic Study of Aortic Dissection Evolution

Project Summary/Abstract:
The natural evolution of aortic dissection is notoriously unpredictable under current methods of evaluation and
management. There is an urgent need to more completely elucidate the biomechanical stability of type B aortic
dissections and identify signatures in the imaging data allowing for optimal patient classification based on aortic
fragility. The long-term goal is the development and validation of image-based analysis algorithms to classify
aortic stability and allow a personalized risk stratification for a given patient’s aortic geometry providing the basis
for optimizing clinical management. The overall objective of this proposal is to utilize modern approaches in
differential geometry, continuum mechanics, and computer vision to discover and characterize high-risk
geometric structures hidden within computed tomography angiography (CTA) data of fragile aortas. The central
hypothesis of this application is the existence of a fundamental link between aortic shape and aortic stability as
it relates to the risk of aortic dissection and fragility. The rationale for this work is development of an easily
translatable geometry and mechanics-based algorithm to predict dissection stability and intervention timing by
discovering a richer and more nuanced mapping of aortic shapes hidden in existing patient imaging data. The
central hypothesis will be tested by pursuing three specific aims: 1) develop a modern geometric classification
for aortic shapes, 2) develop a computational model that provides the mechanism underpinning the shape
evolution of aortic dissections, and 3) develop a modern successor to the traditional ‘maximum diameter’
measure of aortic dissections that integrates geometric, finite element, and physiologic factors. Utilizing a large
pre-identified CTA data set of normal and dissected aortas at various stages of disease and intervention, aim 1
will use tools from computer vision to reduce aortic shape to distributions of shape index and curvedness. Aim 2
will utilize advanced morphoelastic finite element growth models to discover the biomechanical mechanism
underpinning aortic shape changes in aortic dissections and validate these models on patient specific geometries
over clinically relevant time periods. These novel shape and mechanical stability classifiers will be used in both
linear and non-linear dimensionality reduction methods to define aortic shape sub-spaces for different clinical
scenarios in aim 3. This proposal is innovative as it challenges the status quo of evaluation and treatment by
deploying novel measures and techniques that analyze clinically relevant aortic geometry and the evolution of
aortic shape. Every patient is taken to the operating room under the full intent of having a positive clinical
outcome. The research outlined is significant because it is expected to provide surgeons and patients a more
discriminative framework with which to make better informed management decisions concerning type B aortic
dissections and ultimately optimize outcomes.

Public health relevance
Project Narrative: The proposed research is relevant to public health because it seeks to inform upon the potential benefits of surgical versus medical intervention for type B aortic dissection through the development of modern geometric and mechanistically based selection criteria. Upon completion there will be a richer and more nuanced understanding of aortic stability as defined from computed tomography angiography imaging, which will allow for more optimal patient selection. Thus, the proposed research is relevant to the part of the NIH’s mission to enhance cardiovascular health and improve mortality.